Development and Assessment of Virtual Reality Paradigms for Gaze Contingent Visual Rehabilitation

Abstract Stroke-induced occipital damage is an increasingly prevalent, debilitating cause of partial blindness, which afflicts about 1% of the population over age 50. Over the last 10 years, new methods for visual retraining have emerged, and they have been shown to locally recover a range of visual abilities in previously cortically blind (CB) fields. Although exciting and life altering for patients, effective training has been restricted to the laboratory under the supervision of a technician as an eye tracker is used to target delivery of the stimulus at the edge of the blind field. At home, where patients do most of their training (300-600 trials/day, 5-7 days/week for a minimum of 3-6 months), and no eye tracker is involved, involuntary eye movements cause many stimuli to fall outside of the intended area. As a result, training effectiveness is severely reduced. The work proposed to be executed out at the Perform Lab at the Rochester Institute of Technology leverages recent advances in eye tracking and virtual reality technology for effective at-home visual rehabilitation. Hardware and software development will be followed by replications of published psychophysical experiments conducted with traditional desktop displays, and quantitative comparisons will be used to assess the effectiveness of the novel apparatus. At the same time, new paradigms will probe the potential of virtual reality as a means to study behavior in more naturalistic contexts in which conclusions are drawn from experimental records of movements of the hands or eyes to dynamically-changing, audio-visual stimuli, embedded within a three-dimensional task environment.

Public health relevance
Project Narrative Over the last 10 years, new methods have been developed for visual retraining in cortically blind (CB) fields following stroke, and these methods have been shown to locally recover a range of visual abilities in previously blind fields. Because efficient training has been limited to the laboratory in the presence of research-grade eye trackers, we propose to transfer these paradigms into a virtual reality (VR) display with an affordable integrated eye tracker for visual retraining at home. Psychophysical investigation is used to validate the functionality of this modified approach, and to assess the effectiveness of new paradigms in VR that involve the use of multisensory stimuli embedded in the world reference frame.